Functional and Pathological Interactions of TDP-43

Project Summary
Cellular inclusions of proteins are primary hallmarks of a great majority of neurodegenerative diseases. In
common forms of amyotrophic lateral sclerosis (ALS), Alzheimer’s disease related dementias (frontotemporal
dementia; limbic-predominant age-related TDP-43 encephalopathy (LATE)) as well as some forms of
Alzheimer’s disease, the essential human TAR DNA binding protein of 43 kDa (TDP-43) forms intraneuronal
aggregates. Importantly, dozens of missense mutations in an aggregation-prone domain of TDP-43 have been
found in familial and sporadic cases of ALS and frontotemporal dementia. These data provide strong support
for the direct causative pathological role for TDP-43 in neurodegeneration in Alzheimer’s disease related
dementias and motor neuron disease. Additionally, recent research modulating the TDP-43 interactome
demonstrates that TDP-43 is an important potential therapeutic targets in these diseases. However,
therapeutic development is hampered in large part by an absence of mechanistic understanding of normal
TDP-43 function, the molecular effect of the mutations causing amyotrophic lateral sclerosis and
frontotemporal dementia, and the TDP-43 disruption in neurodegenerative disease. These gaps are due in
large part to a lack of atomic structural data regarding TDP-43, its complexes, and its conversion to
aggregates, which in turn is due to the difficulty in observing TDP-43 complexes via traditional structural
biology techniques. This project will make use of integrated experimental and computational structural biology
techniques combined with molecular and cell biology approaches to 1) determine the atomistic details of the
assembly of a helical sub-region of TDP-43, its contribution to splicing function, and its structural conversion in
disease aggregates, 2) identify how known and novel post-translational modifications and disease-associated
mutations alter TDP-43 self- and hetero-protein contacts that mediate and regulate TDP-43 liquid-liquid phase
separation and disease-associated aggregation, and 3) map the structural basis of the interactions of TDP-43
with poly(ADP-ribose) and importin machinery that serve as promising therapeutic targets. The challenging,
dynamic, structural targets necessitate the approach highlighting a tight connection between molecular
simulation and experimental biophysical techniques (primarily NMR spectroscopy). These approaches will
generate detailed molecular models of the interactions that will be tested for functional relevance using in cell
aggregation, in cell splicing, and in cell protein/RNA binding structure (iCLIP). The results of these studies on
TDP-43 complexes, phase-separation, function, and aggregation will provide direct structural and mechanistic
input to the design of strategies to prevent toxic disruption of TDP-43 in Alzheimer’s disease related dementias
and motor neuron disease. These insights represent potential for future treatments for ALS, frontotemporal
dementia, and other TDP-43-associated diseases that currently have no cure or effective treatments.

Public health relevance
Project Narrative Neuronal deposits or inclusions of the essential human protein TDP-43 are a key feature in many patients suffering from Alzheimer’s disease related dementias including frontotemporal dementia and limbic-predominant age-related TDP-43 encephalopathy, and the motor neuron disease amyotrophic lateral sclerosis. Importantly, small chemical changes in TDP-43, including those caused by TDP-43 gene mutations and intracellular modifications, are associated with disease. Therefore, visualizing the structural details of the TDP-43 along its lifecycle with atom-by-atom chemical resolution is an important step to finding new treatments for incurable neurodegenerative diseases of aging.